Administrative Core

SUMMARY
The Administrative Core (AC) will catalyze, facilitate, support, coordinate, monitor, evaluate and disseminate
tobacco regulatory research being conducted at the University of Pennsylvania-Rutgers University TCORS
(UP-RU TCORS). The AC serves as hub for all four research projects, the Career Enhancement Core (CEC),
which includes a pilot project program, the Tobacco Industry Marketing (TIM) Core and the Biosample Analytic
and Regulatory (BAR) Core. The Rapid Response Projects (RRP) Program will be directly administered via
the AC.
The AC will utilize strategic planning, evaluation processes and establish benchmarks and milestones to
ensure that high quality, rigorous tobacco regulatory science is conducted within our center. The AC will also
serve as the primary point of contact for communication and collaboration with external entities, including the
Food and Drug Administration Center for Tobacco Products, the National Institutes of Health, other TCORS,
the Center for Coordination of Analytics, Science, Enhancement, and Logistics (CASEL) in Tobacco
Regulatory Science, and other investigator teams interested in collaborative opportunities in tobacco regulatory
science.
The UP-RU TCORS assembles a multi-disciplinary team of experts who are committed to tobacco regulatory
science to conduct four highly integrated research projects that share a common theme: Examining the
Effects of Advertising, Packaging and Labeling on Perceptions, Use and Exposure of Combustible
Tobacco Products.
There are essential activities required to provide leadership within the UP-RU TCORS as well as leadership
with external stakeholders and collaborators. It is the goal of the AC to provide the required leadership and
guidance so that every potential opportunity is identified and met to accelerate the accrual of highly rigorous,
informative tobacco regulatory science research.
The AC will: monitor and evaluate progress of the UP-RU TCORS projects; enhance team-based tobacco
regulatory science and facilitate collaboration; support pilot project applications, and catalyze efforts between
projects and cores; provide RRP coordination and oversee the conduct of RRPs; facilitate and disseminate
communication and collaboration with other TCORS, federal agencies and all tobacco regulatory science
stakeholders; and provide administrative and budgetary oversight of the UP-RU TCORS.